Core C: Biostatistics

SUMMARY/ABSTRACT (Core C)
Core C (Biostatistics) is a new Research Support Core in the revised application and will be
led by Dr. Paul Wileyto. In the previous application, the Biostatistics services were included
under Core A (Administrative Core). This Program Project tests hypotheses related to the idea
that Integrated Stress Response (ISR) mediates MYC-dependent and hypoxia-dependent tumor
progression. The observables directly resulting from in-vitro and in-vivo experiments include
direct observation of tumor cell death, tumor cell survival and growth, latency to tumor formation,
and host survival. These outcomes are easily approached by standard statistical procedures
that have been developed for laboratory and clinical studies. The Aims of this new Biostatistics
Core in the proposed funding period are: Aim 1. To provide Biostatistics support to the all
Project Leaders and co-Leaders in the following areas: a) Design of studies involving in-vitro
and in-vivo experiments that do not fall under the umbrella of metabolomics and bio informatics.
Aim 2. To perform Statistical modeling and Statistical analysis to evaluate each project's
research hypotheses. Aim 3. To interpret research data and collaboration with investigators to
make scientifically and statistically appropriate statements, and to also provide assistance in the
preparation of scientific abstracts, presentations, and manuscripts.

Public health relevance
PROJECT NARRATIVE (CORE C) The overall goal of Core C is to interact with all project Leaders and their lab members on study design, data analysis and data interpretation as well as to evaluate methods related to quantification and data analysis to ensure rigor and reproducibility in the studies performed under this Program Project.